Transcriptomic Diagnosis and Staging of Sepsis-Associated Acute Kidney Injury

Acute kidney injury is diagnosed in over 50% of patients with sepsis. Sepsis-associated AKI
(sAKI) contributes to high mortality, the development of chronic kidney disease (CKD) and end-
stage renal disease (ESRD). Despite decades of investigation into the pathophysiology and
treatment of sepsis and associated kidney injury, we remain without diagnostic tools to stratify
human AKI etiology and stage, which we seek to address in this proposal. The overall goal of
our project is to test the hypothesis that murine blood transcriptomics can be used to diagnose
and stage human sAKI. We will first identify murine blood-based biomarkers(miRNA and
mRNA) reflective of sAKI tissue injury. We will then use the murine biomarkers to stratify human
AKI according to sAKI diagnosis and molecular stage. The immediate outcome of this work will
be the development of a liquid biopsy to diagnose and stage human sAKI. Indiana University
houses the Biobank Cohort of Indiana and is an established tissue interrogation site for the
Kidney Precision Medicine Project (KPMP), thus, my interdisciplinary mentoring team and I are
well-positioned to undertake this highly translatable work. The current proposal will develop a
number of skills required to be a successful, independent translational researcher.
While my long-term goal is treatment of sAKI, the implementation of this necessitates solid basic
science and computational skill sets. This will allow for future work focused on the treatment of
sAKI. If these studies show efficacy in the diagnosis and staging of human AKI, these strategies
may be rapidly translated into the clinical setting.

Public health relevance
Sepsis is a lethal condition commonly complicated by kidney failure (AKI) yet, despite decades of investigation we lack reliable predictors and treatment. In the present study we will utilize mouse models of sepsis associated AKI (sAKI) to establish blood-based biomarkers correlated with critical stages in the pathogenesis of renal tissue injury which will be used to diagnose and stage human AKI blood samples. The immediate outcome of this work will be the development of a liquid biopsy to diagnose and stage human sAKI.